Implementation of a NY State food/feed safety all hazards rapid response team

Abstract: The New York State Department of Agriculture and Markets has an expansive food and feed safety inspection and regulatory program that covers all food, feed and dairy products that are manufactured, distributed and sold in New York State. The New York State Food Laboratory, a division within the Department of Agriculture and Markets, is New York State's primary food and feed safety laboratory and is accredited to the ISO/IEC 17025:2005 standard and additional criteria set by the AOAC-I ALACC. The New York State Food Laboratory has comprehensive testing programs for foodborne pathogens and chemical residues/toxic elements in food and beverages. If funded by the FDA the New York State Department of Agriculture and Markets will implement an all hazards food and feed emergency Rapid Response Team (RRT) utilizing a multi-agency integrated approach to include our regulatory food and feed safety partners at the local, state, and federal levels.

Public health relevance
Project narrative: The New York State Department of Agriculture and Markets has comprehensive food and feed safety inspection regulatory program that includes state of the art laboratory testing resources. Support from the FDA will enable the creation and implementation of an all-hazards food and feed emergency Rapid Response Team (RRT) within the New York State Department of Agriculture & Markets and among our regulatory food and feed safety partners at the local, state, and federal levels. __SpecificAimsTextDelimiter__ Specific Aims: 1. Develop and implement the Rapid Response Team (RRT) model in New York State through expansion of current collaborations involving food and feed safety regulatory programs within our agency and between our agency and local, state, and federal food and feed safety partners 2. Convert paper-based sample collection and reporting systems to electronic systems that will allow rapid communication of regulatory inspection reports and workflow monitoring for collecting, testing, and reporting data from regulatory food and feed samples in New York State. A key goal is to facilitate communication of data to FDA directly and through eLEXNET. 3. Improve laboratory systems for data capture and reporting through the implementation of a new Laboratory Information Management System (LIMS) 4. Expand communication, outreach, and training opportunities for inspectors and laboratory personnel by leveraging existing activities in the FDA Partnership for Food Protection workgroups. CDC PulseNet, and professional associations including the APHL, AFDO, IAFP, and AAFCO. Expected outcomes: If funded for three years we will develop and implement an all hazards Rapid Response Team in New York State that will incorporate a multi-agency integrated approach to addressing emergencies in food and feed safety. Specific objectives: If funded we intend to take a very practical and applied approach to enhancing food and feed safety programs and response to outbreaks of foodborne and feed-borne illness. Our primary objectives are to: 1. Identify gaps in a rapid unified response to food and feed emergencies n New York State. 2. Make targeted improvements to the integration of local, state and federal resources in New York State (and beyond) to respond to food and feed safety issues. This will be accomplished through the use of an all hazards, multi agency, Rapid Response Team. 3. Maximize the opportunities for the data generated by New York State to be used for national and international regulatory action. 4. Support goals and activities aimed at promoting a fully integrated food safety system.